Neural Mechanisms Controlling Breathing In Mammals

Research addressing the main specific aims of this project focused on cellular and circuit mechanisms generating the respiratory rhythm and neural activity patterns in the brainstem of rodents. Experimental studies were performed with isolated in situ perfused brainstem-spinal cord and in vitro brainstem slice preparations from neonatal or mature rats and mice. Previously we have identified the brainstem locus, called the preBotzinger complex (preBotC), that contains populations of neurons critical for respiratory rhythm generation. We have further exploited methods for real-time structural and functional imaging of these neurons, as well as neurons in rhythm-transmission circuits, utilizing structural imaging performed simultaneously with functional activity imaging by multi-photon laser scanning microscopy of the neurons labeled with fluorescent genetically-encoded calcium sensor and/or fluorescent proteins. This imaging approach has facilitated the identification of respiratory circuit neurons for electrophysiological studies of biophysical and synaptic properties as well as molecular studies of the expression of neuron membrane channels, receptors, and neurotransmitter-related proteins. With these approaches, we have performed high-resolution spatiotemporal imaging of neuron activity and analyzed the biophysical properties of respiratory neurons in the neonatal rodent preBotC in vitro. These studies provide the most direct experimental evidence to date that rhythm generation involves an excitatory network of neurons with specialized cellular properties that endow respiratory circuits with neuronal voltage-dependent mechanisms for producing respiratory oscillations. By applying optogenetic approaches we have previously established that a critical population of glutamatergic neurons with voltage-dependent oscillatory properties is the substrate for inspiratory rhythm generation in the preBotC in the neonatal and adult rodent nervous systems. Studies of neuronal synaptic interactions and cellular membrane biophysical properties in the preBotC, including with intracellular recording techniques in situ continue to support our hybrid pacemaker-network model that was formulated from previous work to explain the generation and control of respiratory rhythm in the intact mammalian nervous system. Studies in progress based on intracellular recording approaches applied in situ are analyzing in detail how distinct populations of excitatory and inhibitory neurons interact to generate the respiratory rhythm and pattern as well as to test predictions of our network models. Furthermore, our in-progress optogenetics-based studies with transgenic mice and novel transgenic rats involving photo-inhibition or photo-excitation of inhibitory respiratory neurons have established a fundamental role of inhibitory microcircuits including in the preBotC in respiratory pattern generation. Other studies have provided additional evidence that neuronal persistent sodium currents and several types of leak or background conductances represent critical ionic conductance mechanisms for the generation and control of respiratory oscillations. Our previous molecular profiling with RT-PCR of messenger RNA expressed in single functionally identified neurons in vitro, as well as our current immunohistochemical and pharmacological studies, have identified a specialized set of transient receptor potential (TRP) cationic channels that also represent important regulators of neuron excitability and current studies are directed toward understanding how these channels may contribute to electrophysiological behavior of respiratory circuit neurons. Other electrophysiological studies have demonstrated that leak conductance mechanisms are critically involved in the regulation of rhythmic breathing patterns by a diverse set of endogenous neurochemicals that modulate these conductances as well as by physiological control signals including carbon dioxide and oxygen. In addition, we continue to conduct novel studies of the role of astrocytes in modulatory control of neural circuit activity in the preBotC, including by the release of signaling molecules such as ATP, which is hypothesized to excite the rhythm-generating neurons, in response to elevated carbon dioxide (hypercapnia) or reduced oxygen (hypoxia) in vivo, including in pathophysiological conditions. By employing viral vectors that selectively interfere with the release of glial transmitters or disrupt ATP-mediated signaling, we have obtained additional evidence that astrocytes respond to hypercapnia and hypoxia in vivo to regulate the activity of preBotC circuits to homeostatically adjust the breathing frequency to partially compensate for these physiological disturbances. In our previous and ongoing studies employing novel chemogenetic approaches applied in vivo, neurons of the retrotrapezoid nucleus (RTN) that have chemosensory properties are also demonstrated to provide a critical excitatory modulatory input to core components of the respiratory network including the preBotC to regulate the generation of inspiratory neural activity. Our new studies showing the involvement of astrocytes in chemosensory regulation at the level of the preBotC have led us to propose new conceptual models for the physiological regulation of key respiratory circuits that incorporate multiple neuromodulatory control mechanisms including astrocytic mechanisms. We are currently extending our optogenetics-based studies to manipulate the activity of regionally specific neuronal and astrocyte populations to further investigate how these different populations contribute to the generation and control of respiratory neural activity in various (patho)physiological states.